Does age/stress-induced mitochondrial dysfunction induce variations in RPE phenotype in AMD?

Project Summary
Age-related macular degeneration (AMD) coincides with retinal pigment epithelium (RPE)
heterogeneity. While ordered cellular heterogeneity is beneficial, pathogenic subgroups resulted
from age/stress-related heterogeneity could lead to age-related diseases. Aging and cigarette
smoking (CS) are the two strongest non-genetic factors associated with AMD risk. The
mechanisms whereby aging and CS drive RPE heterogeneity and these focal AMD changes are
unclear. RPE mitochondrial (mt) dysfunction is a well-established pathogenic factor in AMD, and
both aging and CS induce mt dysfunction. We recently reported that modest mt dysfunction
from impaired mitophagy can trigger reactive oxygen species (ROS) mediated retrograde mt to
nuclear signaling and RPE epithelial-mesenchymal transition (EMT), which has been identified
in human AMD tissue. Senescence is a specific, terminal cellular program that induces cell
cycle arrest with aging, and/or metabolic and oxidative stress. Even small numbers of senescent
cells can drive age-related disease. We recently reported that mice deficient of mt phosphatase
PGAM5 had mt hyperfusion, which induced significant mt dysfunction associated with changes
in ROS and ATP level. As a result, a subset of RPE became senescent due to dysregulated
AMPK/mTOR signaling. Similarly, our pilot data show that RPE senescence and EMT can be
induced by non-lethal Cigarette Smoke Condensate (CSC). These observations suggest that mt
dysfunction severity from aging/CS can initiate RPE heterogeneity. Our objective is to
determine how aging and smoking induced mt dysfunction severity triggers RPE heterogeneity
including EMT and senescence, to link these phenotypes with RPE dysfunction and an AMD
phenotype in animal models, and identify the molecular identity of RPE heterogeneity including
EMT and senescence in a smoking model of AMD and human AMD samples. Our hypothesis
is that RPE mt dysfunction severity from smoking and aging induces RPE heterogeneity
including EMT, senescence, and cell death, which will be tested in two specific aims (SA). SA I
is to determine the extent that mt dysfunction severity from aging drives RPE
heterogeneity through regulating mt dynamics. SA II is to determine the extent that mt
dysfunction severity from smoking, especially when combined with aging, promotes RPE
heterogeneity and an AMD phenotype. By the end of proposed project, we will have
experimentally linked mt dysfunction severity with RPE EMT, senescence, and cell death, and
identified therapeutic targets to test for dry AMD, a long-term goal of our labs.

Public health relevance
PROJECT NARRATIVE Advanced age and cigarette smoking (CS) are the top non-genetic risk factors for age-related macular degeneration (AMD). The extent that aging and CS drive mitochondrial dysfunction and variable RPE phenotypes is still unclear, representing significant scientific knowledge gap in the field. This proposal will characterize the cellular and molecular features of disease-causing subtypes in RPE cells, including epithelial mesenchymal transition (EMT), senescence, and cell death, and link those with the severity of mitochondrial dysfunction associated with aging and CS in both animal models and human AMD samples.